Immune and Genetic Controls of Tissue Regeneration in Mice and Humans

Abstract/Summary
Cutaneous wounds create significant health problems for Veterans, including wartime trauma, diabetic foot
ulcers, pressure ulcers, and pathological scar formation. We aim to devise novel methods to stimulate self-
repair mechanisms and to promote scar-less wound healing/full tissue regeneration in humans. We use a
combination of loss-of-function mouse genetics, parabiosis (where the circulatory systems of two mice are
surgically connected), mass cytometry, flow cytometry, genomics, lineage tracing, and molecular biology to
study ear tissue regeneration in mice. Our prior work and current preliminary data demonstrate that in two
different physiologic contexts, skin-secreted SDF1 regulates the switch between scar formation and tissue
regeneration. In Aim 1, we will study how SDF1 promotes scarring and fibrosis. The canonical receptor for
SDF1 is CXCR4. After injury, we hypothesize that skin-secreted SDF1 recruits CXCR4+ immune cells, which
produce paracrine factors that induce fibroblasts to form fibrous tissue and scar. Recruited cell types will be
defined and functionally tested. In Aim 2, we translate our findings directly into humans. While pathologic scar
formation (keloids and hypertrophic scars) is more common in certain ethnicities, the genetic basis of keloid
formation remains unknown. We hypothesize that increased SDF1 promotes formation of human pathologic
scars. Indeed, human keloid tissue contains higher amounts of SDF1. We propose to identify single nucleotide
polymorphisms in the SDF1 gene of keloid-prone and control patients. Identified polymorphisms will be
introduced and functionally tested in an ex vivo human skin organoid system. This proposal seeks to
understand how SDF1 regulates wound healing and tissue regeneration and to decipher the genetic basis for
pathologic scar formation in humans.

Public health relevance
Project Narrative Cutaneous wounds create significant health problems for Veterans, including wartime trauma, diabetic foot ulcers, pressure ulcers, and pathological scar formation. 6.5 million chronic cutaneous wounds appear annually on patients, and 25 billion dollars are spent annually on treatment. Current treatment paradigms are woefully ineffective and represent a clinically unmet need. We aim to develop new therapeutic approaches to tissue repair based upon a deep understanding of the molecular mechanism and a firm commitment to the clinical/translational mission. Our work identified a signaling pathway that regulates whether a wound heals with or without a scar in a mouse ear. We aim to learn more about how this regulatory switch functions, and we will assess whether this signaling pathway regulates pathological scar formation in humans.